Methods for profiling the cancer virome and microbial strain genetics

Project Summary
An increasing body of research links the human microbiome to cancer by a variety of mechanisms, including
pathogenesis, immunity, and response to treatment (not to be confused with the more controversial, recently
publicized, but unrelated role of putative tissue-resident microbes in cancer). Major knowledge gaps remain,
however: while viruses such as HPV, Epstein-Barr virus, and hepatitis are well-known to drive carcinogenesis,
not one of the many recent large-scale cancer microbiome studies have tested for endogenous viral
involvement. This is due not to a lack of interest, but to the unavailability of computational tools to accurately
identify non-bacterial microbial community members. Similarly, just as small variations in the human genome
can profoundly alter phenotype, dramatic genetic and phenotypic differences are common among microbial
strains of the same species. Again, only within the past few years have accurate methods become available to
genotype microbial community members at scale from shotgun metagenomes. Almost no studies have as yet
leveraged this new information, however, since again no biostatistical methods have been established to do
so.
We will thus address both of these methodological gaps in the analysis of cancer-associated viral microbiome
members and microbial strain genetic variants by, first, developing computational methods for virome profiling
from shotgun metagenomes and metatranscriptomes. These will be initially driven by applications to stool
microbiomes from the CRC adenoma-to-carcinoma continuum, but also appropriate for other cancer
microbiomes. They will integrate viral nucleotide and amino acid reference sequences with the lab’s published
taxonomic profiling algorithms, in combination with deep learning for viral identification and quantification from
long reads and assembled contigs. We will validate and apply these methods to a meta-analysis of 3,512 CRC,
adenoma, and control stool shotgun metagenomes that have been collected, curated, and uniformly
preprocessed from 16 existing studies to identify newly-detectable viruses significantly enriched or depleted in
the CRC gut.
Second, we will develop biostatistical methods for analysis of microbial strain genetic variants and phylogeny in
malignancy-associated microbiomes. Again, these will be initially applied to CRC metagenomes, but are
applicable to any cancer microbiomes. These methods will adapt a combination of regularized regression and
phylogenetic linear mixed models (PGLMMs) to detect strain-specific genetic elements and phylogenetic
lineages significantly present or absent during cancer outcomes. We will validate and apply them to the same
CRC meta-analysis data collection. This will provide the first identification of strain-specific microbial genes and
evolutionary selection pressures in the endogenous microbiome specific to colorectal carcinogenesis.

Public health relevance
Project Narrative This project will develop innovative computational tools to enable viral profiling and microbial strain epidemiology in cancer microbiome research. The former will provide the first comprehensive DNA and RNA viral identification from whole communities by integrating nucleotide and amino acid reference sequences with deep learning methods; the latter will use robust statistical models to link microbial genetic variations with cancer phenotypes. These tools will be validated using a comprehensive meta-analysis of colorectal cancer- related metagenomes, addressing critical gaps in understanding the microbiome's role in cancer development and treatment response